A Synchrotron Radiation Structural Biology Resource

Summary/Abstract - P30GM133894
Synchrotron radiation (SR) is an extremely bright and tunable x-ray source that enables forefront
research in structural molecular biology (SMB). The goal of “A Synchrotron Structural Biology
Resource" at the Stanford Synchrotron Radiation Lightsource (SSRL) is to provide users access
to an integrated, mature SMB Resource with state-of-the-are synchrotron beam line facilities for
macromolecular crystallography, x-ray absorption/emission/imaging spectroscopy and small- and
wide-angle x-ray scattering/diffraction, techniques that form the three Resource’s Technical
Operations Cores. Special emphasis is given to providing a high level of dedicated user support
and services, to training of the users, and to performing extensive outreach on the scientific
benefits of the capabilities of these specialized, yet mature facilities to the biomedical research
community. Users are able to carry out experiments either on-site or from their home institutions
by using sophisticated remote access instrument tools. User access is based on single
experiment or program type proposals which undergo a transparent and robust external peer-
review process. A multifaceted training and outreach program includes individual training,
workshops, summer schools, on-the-road mini workshops, and internships by the Resource’s
experienced science and technical staff, supplemented by outside experts. Training will also
include techniques that complement those provided by the 3 Resource’s TOCs so as to educate
users as to optimal multi-technique research strategies for solving their most complex problems.
The Resource’s web portal provides streamlined scientific, technical, training, outreach and
administrative material and other relevant information for the users, our sponsors and the general
public. A principal aim is to optimize and maintain, for reliable and forefront performance,
experimental facilities and instrumentation, detectors, software and computing and network
capabilities on the SMB Resource’s 8 beam lines at SSRL, capitalizing on the high SR x-ray
performance of SSRL’s 3rd generation storage ring SPEAR3, and at the MFX station at LCLS.
With a specialized focus on user training, support and service, the SMB Resource will enable the
scientific success for challenging and routine projects in the biomedical sciences.

Public health relevance
Narrative Statement - P30GM133894 The purpose of the P30 Resource is to provide the biomedical community with access to state- of- the-art facilities for macromolecular crystallography, small- and wide-angle x-ray scattering, and x-ray spectroscopy/imaging, tools that are essential for the study of biological systems. They enable information that is prerequisite for understanding fundamentals of life, and provide methods that are central to the development of new therapeutics for human disease. The overarching goal is to provide an integrated Resource that makes mature technologies available to a broad research community, and provides researchers with expert support in their use.